Sturge Weber Syndrome: Moving Translational Science Forward into the Clinical Realm

Project Summary/Abstract
The Sturge-Weber Foundation (SWF) is requesting funds for a meeting in 2023 where clinical
and basic science research conferences will be combined in a new format to accelerate the
pace of translational research in the Sturge-Weber community. The theme for the meeting is
“Moving Translational Science Forward into the Clinical Realm”. This meeting will bring together
a diverse group of participants to translate recent research findings about Sturge-Weber
Syndrome (SWS) into new clinical trials. This meeting was last held in 2022 as two separate
events, and the program for 2023 is designed to bring together both established and junior
researchers and clinicians along with a diverse panel of experts in the study and treatment of
SWS. Activities during the meeting will be designed to maximize the interaction between senior
and junior investigators, to help encourage a new generation of physicians and scientists
studying SWS and related neurovascular disorders. SWS is a rare neurocutaneous disorder
caused by a somatic mosaic mutation in the GNAQ gene and is characterized by vascular
malformations in the brain, skin, and eyes, leading to a range of symptoms including seizures
and chronic pain. Despite treatment, many individuals with SWS continue to experience
significant challenges in their daily lives. The SWF provides support and resources for
individuals and their families living with SWS. The 2023 meeting will be held at the Marriott
Courtyard in Chapel Hill, North Carolina. This site is convenient and affordable for travel for all
of our attendees, and we plan to offer travel stipends for young scientists and physicians as we
strive to build an equitable program for all. We expect that the discussions and presentations at
this conference will improve our understanding of the molecular mechanisms behind Sturge-
Weber syndrome and lay the groundwork for developing new treatments for the disorder. The
conference's poster sessions and other informal interactions among participants will also
promote collaboration and advance research in this area.

Public health relevance
Project Narrative We have a long and successful track record of independent clinical and research meetings to advance the research and care of patients with Sturge-Weber Syndrome. For our meeting in 2023, we will combine the clinical and basic sciences together in a new format entitled "Moving Translational Science Forward into the Clinical Realm." The meeting has already recruited and continue our outreach for a highly diverse group of seasoned and junior participants who will work to translate pathophysiology and genetics of this rare disease into new clinical trials to improve the lives of patients with Sturge-Weber Syndrome.